Outcomes and Affordability of Observation Status for Children (OASIS)

PROJECT ABSTACT
It is estimated that ~500,000 (34%) pediatric hospital stays each year in the United States (US) are
designated as outpatient under “observation status” and often referred to as observation stays. The concept of
observation status was created, initially, as a clinical designation, primarily for Emergency Department (ED)
clinicians to “observe” the patient for a period of time to determine the need for inpatient care (e.g., inpatient
admission). Over the past three decades, observation status has evolved and now is used as an administrative
assignment for patients who have a “short-term” hospital stay, typically falling “under the 2-midnight rule,” as
originally defined for Medicare patients and now widely adopted by commercial insurers and Medicaid
agencies. Our team recently found that observation stays are now common for pediatric hospital stays,
especially for children undergoing surgery. For example, more than 50% of pediatric post-appendectomy
admissions at Children's Hospitals were billed as observation stays in 2019. Studies from adult patients have
found significant impact of omitting observation stay data on quality measures and financial implications of
observation stays on patient Out-Of-Pocket (OOP) costs, yet there is a paucity of information about the impact
and implications on pediatric patients. To fill the crucial knowledge gaps, we propose a retrospective
observational study entitled Outcomes and Affordability of Observation Status for Children (OASIS) to
characterize the shift in observation stay assignment of pediatric patients, evaluate the impact of omitting
observation stay data on Pediatric Quality Indicators (QIs), and assess OOP costs for pediatric observation
stays. We focus on Agency for Healthcare Research and Quality (AHRQ) Pediatric QIs and propose to
evaluate the impact of omitting observation stay data on these QIs using Healthcare Cost and Utilization
Project state specific databases from 2010 through 2019. Specifically, we will quantify the overall and specific
trends in observation stay assignment by patient characteristic (e.g., race/ethnicity), evaluate the impact of
omitting observation stay data on the Pediatric QIs, and examine if there are any disparities in the trends and
QIs calculations. We also propose to assess OOP costs for pediatric observation stays by leveraging claims
data from statewide All-Payer Claims Databases and Optum. We will first characterize unexpected OOP cost
components that are typically covered by inpatient insurance benefits, such as medications, and identify
conditions for which OOP costs are higher as an observation stay than as an inpatient stay. The OASIS study
will provide pediatric specific evidence to refine quality measures, to develop advice for patients to recognize
financial implications of observation stays on OOP costs, and to inform future policies to protect patients in
observation stays from paying more than they would as inpatients.

Public health relevance
PROJECT NARRATIVE The Outcomes and Affordability of Observation Status for Children (OASIS) study will characterize the shift in observation stay assignment of pediatric patients, evaluate the impact of omitting observation stay data when calculating the Agency for Healthcare Research and Quality (AHRQ) Pediatric Quality Indicators, and assess Out-of-Pocket costs for pediatric observation stays using large-scale health care administrative data.